Immune Genomics and COVID-19 Vaccine Response in Adults with Adverse Childhood Experiences

Abstract
The lifelong influence of adversity during development on gene regulation in the immune system offers insight
into COVID-19 related health disparities. However, the pathways by which adverse childhood experiences
(ACEs) disrupt immune function throughout life are not fully understood and it is unknown how ACEs may
influence COVID-19 vaccine immune response. The conserved transcriptional response to adversity (CTRA) is
a gene expression pattern characterized by up-regulated inflammatory and down-regulated type I interferon (IFN)
anti-viral genes. The CTRA has been recognized across many studies of adverse social conditions including in
young adult and adolescent survivors of trauma. COVID-19 vaccine protection relies upon appropriate
inflammatory and IFN responses by antigen presenting cells (APCs) to initiate lasting immune memory. Two
types of APCs, monocytes and dendritic cells (DCs) have been bioinformatically identified as primary cell types
affected by the CTRA, though direct measurement of gene expression in both cell types has not been performed.
This project will recruit a sample of COVID-19 vaccinated adults with no known prior SARS-COV-2 infection.
The CTRA will be quantified in isolated monocytes and DCs using RNA sequencing and vaccine response will
be determined by circulating antibody concentration and T-cell response in functional assays. We expect that
ACEs will be negatively associated with COVID-19 vaccine response, positively associated with CTRA
associated inflammatory gene expression in monocytes, and negatively associated with CTRA associated type
I IFN gene expression in DCs. Because DCs play a central role in the activation of T-cells and antibody producing
B-cells following vaccination, we expect that antiviral gene expression will be positively correlated with COVID-
19 vaccine antibody and T-cell immunity. This innovative study will elucidate a biological pathway by which ACEs
diminish function of the immune system through molecular deviations in specific cell types. Although the current
vaccines are highly effective at preventing severe COVID-19, the degree of variability in the initial immune
response may influence the longevity of immune protection. Thus, our findings may have implications for
differential booster vaccine recommendations according to history of ACEs.

Public health relevance
Narrative Adverse childhood experiences (ACEs) lead to poor health and short lifespan partly because stress in early life can alter the development of the immune system. This project will examine the effects of ACEs on immune gene regulation and COVID-19 vaccine response. Our results may indicate that people with high ACEs should be prioritized for vaccine boosters.